The Impact of Zinc Intake on Nutritional Status and Brain Development Among Preterm Infants

ABSTRACT
This K23 proposal describes a five-year research and training plan to facilitate Dr. Katherine Bell’s transition
into an independent physician-scientist in the field of neonatal nutrition. Dr. Bell is a neonatologist with a strong
foundation in patient-oriented research. Nutrient deficits occurring during the neonatal intensive care unit
(NICU) hospitalization impair preterm infants’ growth and maturation during a critical period for development of
the body and brain, adversely impacting long-term neurodevelopmental outcomes. The essential micronutrient
zinc is crucial for infant growth and brain development, but the optimal zinc intake for preterm infants is
unknown and current fortification strategies may be insufficient. Accurate assessment of nutritional status in
preterm infants is facilitated by distinguishing lean mass—which reflects organ growth and maturation—from
fat. The goal of this proposal is to determine the association between zinc intake in the NICU and lean mass
accrual (as a marker of nutritional status) and to evaluate the clinical impact of variabilities in zinc intake on
concurrent brain development and later neurodevelopmental outcomes. The hypothesis that greater zinc intake
results in greater lean mass accrual, improved brain growth and maturation, and improved neurodevelopment
will be tested through 3 specific aims: 1) Determine the association of zinc intake in the NICU with lean mass
at term equivalent age. 2) Determine the association between zinc intake in the NICU and brain growth and
maturation. 3) Determine the impact of neonatal zinc intake on neurodevelopmental outcomes at 2 years. This
research is significant for the field of neonatal nutrition, as knowledge gained from this study will help
determine optimal zinc intake for preterm infants and inform the design of nutritional strategies to ensure
adequate micronutrient provision to all preterm infants. Dr. Bell’s mentoring team—Dr. Belfort (primary mentor)
and Dr. Duggan (co-mentor)—provide complementary expertise in preterm infant nutrition and micronutrient
requirements in children, respectively. Dr. Bell will also receive mentorship from distinguished scientists with
expertise in key areas related to this work, including micronutrient biochemistry, breastmilk composition,
neurodevelopmental assessment in childhood, and the developmental origins of disease. The training
opportunities and resources at Brigham and Women’s Hospital, Tufts Friedman School of Nutrition Science,
and Harvard Medical School are an ideal environment for the candidate’s career development. The candidate’s
institution is strongly committed to her success. Dr. Bell’s detailed career development plan includes mentored
research, didactic coursework including a formal degree in nutrition science, seminars, and presentations at
scientific meetings. She presents a timeline for completion of the research aims and preparation of a future
R01 application. The knowledge and training gained from this K23 award will enable Dr. Bell to develop the
skills and expertise required to launch an independent research career focused on designing micronutrient
interventions to optimize growth and long-term health outcomes for preterm infants.

Public health relevance
PROJECT NARRATIVE Premature infants are vulnerable to undernutrition, which negatively impacts brain growth and development with the potential to permanently impair long-term neurodevelopment. This project seeks to clarify the impact that variability in the intake of a specific micronutrient, zinc, during the neonatal period has on growth, concurrent brain development, and later neurodevelopmental outcomes. The long-term goal of this research is to determine optimal zinc intake among preterm infants and identify nutritional intervention strategies to ensure all infants receive adequate zinc intake to support growth and maximize long-term health outcomes.